Data Analysis Core

DATA ANALYSIS CORE – PROJECT SUMMARY
The Data Analysis Core will support all P01 Projects and the Biospecimen Core by providing statistical support
and data analysis. There are three main goals of the Data Analysis Core: 1) Provide biostatistical support to
each Project. Biostatistics experts will consult with each investigator before the onset of each Project to ensure
sufficient power in study design. Biostatistical consultation will be particularly important for the clinical trial in
Project 4, but will aid in model-focused studies as well. Biostatistics expertise will ensure that proper statistical
tests are applied to data and that consistent statistical approaches are used throughout. In order to combine
diverse data, a novel progestin prioritization ranking algorithm will be used to rank progestins for use in Project
4’s clinical trial. 2) Provide bioinformatic analysis of genomics data. Bioinformatics experts will coordinate
analysis of genomics datasets, including RNA-seq, single cell RNA-seq, exome, and CRISPRa/i experiments.
Bioinformaticians will ensure the use of state-of-the-art computational pipelines throughout each Project. The
core will also serve as a data integration hub while working closely with all investigators. 3) Facilitate sharing of
data and analysis results across Projects. Another key role of the Core will be to facilitate sharing of data across
Projects. Cloud-based resources will enable easy and rapid sharing and visualization of genomics data across
Projects as well as specimen tracking and sharing of histological images. The use of a centralized Data Analysis
Core will enhance collaboration across the study while ensuring that rigorous approaches are used during each
aspect of the proposal. By providing these services, the Data Analysis Core will help the P01 achieve the goal
of identifying the most promising progestins for endometrial cancer and atypical endometrial hyperplasia and the
patients that are most likely to benefit.

Public health relevance
DATA ANALYSIS CORE – PROJECT NARRATIVE Progestins, synthetic progesterones, are the only pharmacological agent used to treat primary endometrial cancer and atypical endometrial hyperplasia; however, the best progestin to use and the patients most likely to benefit remain unknown. The goal of the P01 is to identify progestins that are effective and safe as well as biomarkers that predict progestin response. The Data Analysis Core will contribute to this goal by providing biostatistical support, genomic data analysis, and data sharing, which are critical to the success of the P01.